Alveolar injury and repair in Pompe Disease

Project Summary/Abstract
Pompe disease is a rare autosomal recessive disorder caused by a deficiency of acid alpha-glucosidase (GAA)
– a lysosomal enzyme that hydrolyzes glycogen. GAA deficiency results in glycogen accumulation in the
lysosomes of cardiac, skeletal, and smooth muscle as well as motor neurons1-3. Despite treatment with enzyme
replacement therapy (ERT), many patients develop recurrent respiratory infections, restrictive lung disease, and
respiratory insufficiency4,5. As a result, respiratory failure is still the leading cause of death6. Respiratory
compromise was previously attributed to failure to protect the upper airway, diaphragm muscle weakness, motor
neuron pathology, and airway smooth muscle pathology7-10. However, recent findings from our laboratory
identified significant pathology in alveolar type 1 and type 2 (AT1 and AT2) cells as a result of GAA deficiency
and glycogen accumulation. Specifically, we found that GAA deficiency in Pompe disease resulted in engorged
lysosomes which significantly disrupted AT1 and AT2 cellular architecture. Lysosomes are an essential
component of autophagy which is important for maintaining cellular homeostasis. We also found that GAA
deficiency resulted in reduced surfactant protein D gene (SP-D) expression and abnormal surfactant
accumulation11. Building on these novel findings, the central hypothesis of this proposal is that GAA deficiency
disrupts alveolar repair after lung injury and impairs autophagy, and AAV-GAA gene therapy will
enhance lung damage repair and reverse alveolar pathology. Three specific aims will be accomplished using
the Pompe disease mouse – the Gaa-/- mouse. Aim 1 will determine if Gaa-/- AT2 cells successfully differentiate,
repair and repopulate damaged alveolar cells following lung injury. Aim 2 will elucidate the impact of GAA
deficiency on autophagy and cellular homeostasis in AT2 cells. Finally, aim 3 will treat alveolar pathology using
AAV therapy and to combine airway and systemic therapy to treat the global disease. The proposed experiments
will evaluate AT2 cellular function in alveolar repair following a lung injury. We will use a series of ex vivo and in
vivo studies, biochemical and histological assessments of lungs, as well as functional and behavioral studies.
This proposal will uniquely combine the respiratory physiology and Pompe disease mouse model experience of
the PI (ElMallah), with Co-PI Tata’s alveolar stem cell, genetic and epigenetic expertise. This work is innovative
because the impact of GAA deficiency on alveolar repair following lung injury has not been evaluated and will
provide clinically relevant information for future therapeutic interventions. Finally, defining the impact of GAA
deficiency on alveolar differentiation and proliferation in Pompe disease will impact clinical care and inform
clinicians about deficits in lung repair following infectious and aspiration injuries.

Public health relevance
Project Narrative Pompe disease is a rare autosomal recessive disorder caused by a deficiency of acid alpha-glucosidase (GAA) that affects lysosomes in the cells. Pompe disease damages the air sacs in the lungs. This project will examine the impact of lung injury on Pompe disease and the ability of Pompe disease alveolar cells to repair and regenerate. We will also examine the impact of enzyme replacement therapy and gene therapy on the pathology in the alveolar cells.